Functional Effects of PDE11A Alzheimer's-Associated Variants

PROJECT SUMMARY: Functional Effects of PDE11A Alzheimer’s Disease (AD)-Associated Variants
This parent grant explores how age-related increases in expression and ectopic localization of the enzyme
Phosphodiesterase 11A (PDE11A) drive age-related cognitive decline (ARCD). PDE11A is of particular interest
in the context of aging and AD because its expression in brain is enriched in the hippocampal formation—a
region that is critical for episodic memory and is severely impaired in AD. We find PDE11A expression
increases with age in the rodent and human hippocampus and is further elevated in hippocampus of demented
vs. non-demented aged humans with a history of TBI. We have established that these age-related increases in
PDE11A are ectopically enriched in hippocampal “ghost axons”—that is, axonal terminals that are so densely
packed with PDE11A protein that other axonal proteins are occluded. Through mutational analyses, we have
identified intramolecular signals responsible for these age-related increases in PDE11A expression and its
ectopic localization and have shown that Pde11a knockout mice are protected against ARCD. Given that
advanced age is the strongest risk factor for dementia, coupled with the fact that these PDE11A “ghost axons”
are particularly reminiscent of tau proteinopathies that are associated with ADRDs, it is highly interesting that 2
rare PDE11A variants (i.e., R202H and L756Q) have recently been associated with early-onset AD. The impact
of these mutations on PDE11A function were not measured directly; however, expression of the mutants
increased phosphorylation of recombinant tau in an in vitro assay. This PDE11A mutation-induced increase in
p-tau is consistent with the pathophysiology observed in ADRD brains; however, it suggests a PDE11A loss-of-
function that stands in direct contrast to the PDE11A gain-of-function that we observe with normal aging. As
such, we test the overarching hypothesis that AD-related PDE11A mutations alter catalytic activity and/or
subcellular compartmentalization of PDE11A in a manner that fundamentally differs from aging itself,
thereby producing biochemical and behavioral deficits worse than those seen with normal aging.
Across the 2 aims, we take an integrative approach by coupling in vivo and in vitro genetic manipulations with
behavioral, physiological, and biochemical endpoints. In Specific Aim 1, we determine how the AD-related
PDE11A variants alter protein expression, catalytic activity, subcellular compartmentalization, phosphorylation,
and downstream signaling of PDE11A in a hippocampal cell line that endogenously expresses tau and
recapitulates PDE11A age-related proteinopathies. In Specific Aim 2, we determine if elevated expression of
these PDE11A AD-associated variants in mouse hippocampus produces more widespread cognitive decline
than elevated expression of wild-type PDE11A.These innovative studies will provide much needed insight into
the functional consequences of these AD-related mutations and are consistent with the Division of
Neuroscience’s goal to understand how the processes of ARCD intersect with the development of AD.